Systematic elucidation of endosomal trafficking as a therapeutic opportunity in AD using CRISPR-based functional genomics

PROJECT SUMMARY / ABSTRACT
An effective, disease-modifying treatment for Alzheimer's Disease (AD) is an urgent, unmet need. For an AD
treatment to be effective, it will likely have to target early events in AD pathogenesis. Two lines of evidence
point to a central and early role for changes in endolysosomal trafficking in AD pathogenesis: First, several risk
genes associated with late-onset AD (LOAD) function in endocytosis and endolysosomal trafficking.
Intriguingly, a variant in the trafficking factor gene RAB10 recently co-discovered by the Karch lab, which
lowers RAB10 expression, confers resilience to AD. Second, pathological changes in the endolysosomal
system, such as enlarged early endosomes and upregulation of lysosomal enzymes, are some of the earliest
pathological hallmarks of human AD brains. Therefore, our central hypothesis is that endolysosomal trafficking
is a therapeutic target for early intervention in AD. The goal of the proposed research is to elucidate specific
therapeutic targets to correct endolysosomal defects associated with LOAD risk genes in neurons, and to
therapeutically recapitulate protection from LOAD conferred by variants of the RAB10. The Kampmann lab co-
developed a genetic screening platform enabling inducible and reversible repression (CRISPRi) and activation
(CRISPRa) of genes in human cells for genome-wide loss- and gain-of-function screens, and implemented it in
human iPSC-derived neurons. The Karch lab has established a large collection of patient-derived fibroblasts
and iPSCs, and generated CRISPR-corrected isogenic control lines that have enabled us to uncover
phenotypes in iPSC-derived neurons linked to disease variants, including endolysosomal defects. We propose
to combine our innovative approaches for two Specific Aims. The goal of Aim 1 is to identify therapeutic targets
for AD that recapitulate the mechanism of protective RAB10 variants. We hypothesize that the protective
variants in RAB10 counteract the endolysosomal defects associated with AD. We will test this hypothesis in
iPSC-derived neurons and human brains. We found that protective variants in RAB10 reduce RAB10
expression, and conversely RAB10 expression is elevated in LOAD brains. We will conduct unbiased genome-
wide CRISPRi/a screens in WT iPSC-derived neurons to identify genes that control RAB10 levels and may
therefore be therapeutic targets. In parallel, we will conduct genome-wide screens to identify other therapeutic
targets that phenocopy protective variants in RAB10. We will focus on hits that show epistasis with the RAB10
protective variant, which are most likely to phenocopy the effect of the protective RAB10 allele in human
individuals at risk for AD. The goal of Aim 2 is to use our genetic interaction mapping approach to elucidate
connections between LOAD risk genes, the endolysosomal pathway, and associated therapeutic targets. We
will validate the potential of the identified therapeutic targets in a panel of AD patient-derived iPSC-derived
neurons and isogenic controls for an extensive array of endolysosomal and APP processing phenotypes.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because Alzheimer's Disease (AD) is a devastating disease affecting more than 5 million patients and their families in the US, and also a major economic burden: the cost of AD in the US is greater than $250 billion each year. Currently, there is no treatment that slows the progression of AD, let alone a cure, and we urgently need to identify new therapeutic strategies that target early stages in AD pathogenesis. The proposed research will leverage innovative technologies to identify therapeutic targets in the endolysosomal pathway, which is affected early in AD pathogenesis.